COGNITIVE CHANGES IN PSYCHOTIC DEPRESSION

This outpatient study is progessing fairly rapidly. We are now running (IV placement and serial blood draws to assay cortisol) at the rate of two subjects of controls per week. We are close to being able to take a preliminary look at our data.